Research Colloquium for Junior Psychiatrist Investigators

Abstract
The overarching goal of this proposal is to help early career psychiatrist investigators (i.e., mentees) develop and maintain
a research career path via our multi-component Research Colloquium for Junior Psychiatrist Investigators program (the
Research Colloquium). The Research Colloquium aims to strengthen and diversify the psychiatrist-scientist workforce. It
offers team-based and one-on-one mentorship and research career development to mentees in two tracks that differentiate
participants’ current research experience (i.e., beginner and intermediate) across six core research areas including basic
neuroscience and translational research, clinical psychobiology, health services/health disparities research, treatment and
intervention research, alcohol, pain and other substance use research, and military and veteran mental health research. Each
year, the Research Colloquium gives 40-50 early career psychiatrist investigators, a year-round, immersive research
experience. This application seeks 5 years of support to facilitate the in-person components of the Research Colloquium
specifically for the Alcohol, Pain, and Other Substance Use Research Area for the 2023 – 2028 cohorts. Each year, the
funds from this award will partially support a cohort of 15 early research career psychiatrists with interest in Alcohol, Pain,
and Other Substance Use research to attend the in-person components of the Research Colloquium, which include: 1) the
initial 2-day Research Colloquium held contiguous to the APA Annual Meeting; 2) the 6-month follow-up Booster Session
held contiguous to the American College of Neuropsychopharmacology (ACNP) Annual Meeting; and 3) the 12-month
follow-up Booster Session held contiguous to the Society of Biological Psychiatry (SOBP) Annual Meeting.
The specific aims are to: 1) identify current and future senior psychiatry residents, research fellows, and junior psychiatrists
who are promising candidates for successful research careers in the mental health space; 2) assess the strengths, weakness,
areas for improvement, and specific goals to be accomplished by mentees during their participation in the Research
Colloquium; 3) provide a 2-day, intensive mentored training session that will allow mentees to present their current or
proposed research protocols in small group and poster sessions and receive feedback for enhancements and guidance for
future career progression; 4) provide a 1-day, intensive mentored 6-month follow-up booster session where mentees will
present updates on their research and progress towards their goals for the program in small group sessions, discuss any
barriers to their success, and receive guidance to facilitate progress; 5) provide a 1-day, intensive mentored 12-month follow-
up booster session where mentees will present their final research projects in small group sessions and receive guidance on
transition to the next step in their career development; 6) provide mentees with mentoring (i.e., from senior researchers and
statistical mentors) and peer feedback; 7) provide information and resources that will enable mentees to find and obtain
funding and launch successful research careers, as measured by the receipt of grant support or research fellowships,
publication in peer-reviewed journals, or academic appointments at research institutions (i.e., private or public academia or
industry settings); and 8) provide innovative opportunities for ongoing post-Colloquium mentoring and career guidance
through ad hoc webinars, blog posts, and discussion boards housed on the Research Colloquium Online Community.

Public health relevance
Project Narrative/Public Health Impact The Research Colloquium for Junior Psychiatrist Investigators (Research Colloquium) is an innovative multi-component research training, mentoring and career development program that involves interactive pre- and post-colloquium webinars, a 2-day, immersive, mentoring and networking event, a 6-month booster session at the American College of Neuropsychopharmacology Annual Meeting, a 12-month booster session at the Society of Biological Psychiatry, and yearlong networking and mentoring through an online Research Colloquium community. The program helps address the documented lack of psychiatric researchers, especially among women and ethnic minorities, in this country, by providing research experience for early career psychiatrists, including senior residents, research fellows and junior faculty across age, ethnoracial, gender identity and sexual orientation groups, who meet with distinguished senior research mentors to receive advice on their planned research studies. The overarching goal is to encourage early career psychiatrist investigators, especially minoritized populations and women, to develop and maintain a research career path and includes pre- and post-colloquium activities such as webinars, interactive online Q&A sessions, and discussion boards to ensure longer-term mentoring and career guidance to the junior investigators.